A new regulator for Wnt/beta-catenin signaling and prostate tumorigenesis

DESCRIPTION (provided by applicant): Accumulated evidence has shown a significant role for the Wnt/β-catenin pathway in prostate development and tumorigenesis. Dysregulation of cytoplasmic and nuclear β-catenin has been demonstrated to be a key event in tumorigenesis. Thus, the significance of β-catenin in human tumors was corroborated by discoveries of mutations in both β-catenin and the destruction complex components in tumor cells. More than 80% of colorectal cancers possess inactive mutations in the tumor suppressor, APC. Mutations in axin were also found in hepatocellular carcinomas. Moreover, point mutations within the four serine/threonine residues in the target sites of GSK32 were found in β-catenin in a wide variety of human malignancies. Intriguingly, mutations in β-catenin, APC, and other components of the destruction complex are very rare in prostate cancer samples. However, increased nuclear β-catenin has been frequently observed in advanced prostate cancers during the disease progression. Therefore, other pathways/mechanisms may play a dominant role in the regulation of the Wnt/?β-catenin signaling pathway during the course of prostate cancer initiation and progression. In the past, we identified that LAPSER1, also named LZTS2 (leucine zipper putative tumor suppressor 2), is a novel β-catenin interacting protein. The human LZTS2 gene is located on chromosome 10q24.3. This region has been shown to be frequently lost in a variety of human tumors, including prostate cancer. Over- expression of LZTS2 protein affects the subcellular localization of β-catenin, represses the transcriptional activity of β-catenin, and inhibits cell growth. Intriguingly, a functional HIV Rev-like leucine rich, CRM1/exportin regulated nuclear export signal (NES) was identified within the C-terminus of LZTS2. Through this NES site, LZTS2 can enhance the nuclear export of β-catenin and reduce the level of nuclear β-catenin in cells. Using immunohistochemistry approaches, we further demonstrated that LZTS2 is expressed in the cytoplasm of luminal epithelial cells of prostate glands, and its expression is significantly reduced in human prostate tumor samples. These data elucidate an important role for LZTS2 as a novel regulator in Wnt/?β-catenin-mediated transcription, cell growth, and tumorigenesis. Although a critical role for the Wnt/?β-catenin signaling pathway has been established in prostate tumorigenesis, the precise pathways/mechanisms underlying the dysregulation of?β-catenin in prostate cancer cells still remain unclear. Our recent findings that LZTS2 is a β-catenin interacting protein and modulates the activity and cellular localization of β-catenin point to LZTS2 as a novel regulator for the Wnt/?β-catenin signaling pathway Therefore, we propose a series of experiments in this revised RO1 application to address our central hypothesis that LZTS2 negatively regulates the Wnt/?β-catenin signaling pathway and its dysregulation will activate the Wnt/?β-catenin signaling pathway and contribute to tumorigenesis. Three specific aims are proposed as follows: 1) characterizing the biological role of LZTS2 using knockout mouse models, 2) examining LZTS2 expression in human prostate cancers, and 3) investigating the dysregulation of Wnt/?β-catenin signaling by LZTS2 in prostate tumorigenesis. The above specific aims address the significance of LZTS2 in tumorigenesis and identify the novel mechanisms for dysregulation of Wnt/?β-catenin signaling in tumorigenesis. Insights into new diagnostic markers, therapeutic targets and approaches for prostate cancer and other tumors are expected. PUBLIC HEALTH RELEVANCE: Using different experimental approaches, we identified a novel β-catenin interacting protein, LZTS2 (leucine zipper, putative tumor suppressor 2). In this RO1 application, we propose a series of experiments to further investigate the biological role of LZTS2 in tumorigenesis and in the regulation of the Wnt/?β-catenin signaling pathway.

Public health relevance
Using different experimental approaches, we identified a novel β-catenin interacting protein, LZTS2 (leucine zipper, putative tumor suppressor 2). In this RO1 application, we propose a series of experiments to further investigate the biological role of LZTS2 in tumorigenesis and in the regulation of the Wnt/?β-catenin signaling pathway.